Family Connections cluster RCT in Zambia: Impact of a youth and caregiver intervention on virologic status among HIV-positive youth (ages 15-21)

PROJECT SUMMARY / ABSTRACT
While families play a critical role in adolescent management of chronic illnesses, HIV care and treatment
programs rarely engage older adolescents and young adults (AYA) with their family caregivers. Innovative
approaches are needed though, as AYA consistently have worse HIV-related outcomes than adults and lag on
all the UNAIDS 95-95-95 targets. With a tripling in HIV-related deaths among adolescents since 2000, HIV
remains a leading cause of death among AYA in sub-Saharan Africa where most of the world’s HIV+ youth
live. This R01 responds to the disparate burden of HIV-related mortality among AYA and the compelling
evidence from our R34 pilot study on the feasibility and acceptability of an AYA/caregiver group intervention
called Family Connections. The purpose of the R01 is to test the impact of Family Connections on AYA
achieving undetectable viral loads (VL). This intervention draws upon principles of Positive Youth Development
(PYD) and Social Cognitive theory (SCT) to increase social and family support and decrease self-stigma
among AYA, so they may improve their medication adherence and achieve an undetectable viral load. AYA
and caregiver pairs will enroll into the study together. Participants will attend group sessions, with caregivers
and AYA separated for sessions and then brought together at the end of the sessions to share information and
skills learned.
Trained facilitators will lead the group sessions to: 1) improve understanding of HIV among AYA and
caregivers; 2) help AYA develop strategies for healthy living including adherence to ART; 3) build the capacity
of AYA to make informed decisions about their sexual and reproductive health; 4) build the capacity of
caregivers to support AYA; and 5) help AYA develop life skills to communicate their HIV diagnosis
effectively and to plan for their futures. The study design is a cluster randomized controlled trial with 20 HIV
clinics in the Lusaka and Copperbelt Provinces in Zambia. The design will allow us to compare 200 pairs of
AYA and caregivers at 10 intervention clinics versus 200 pairs at 10 control clinics (n=800 total: 400 AYA, 400
caregivers). Our specific aims are to: 1) assess the impact of Family Connections on achieving undetectable
VL (<20 copies/mL) among AYAs; 2) assess the impact of Family Connections on caregiver burden and social
support among the caregiver participants; and 3) examine if the impact of Family Connections on AYAs’ viral
status is moderated by developmental differences among youth assessed through measures of cognitive
functioning, executive functioning, impulse control, and emotional regulation.

Public health relevance
PROJECT NARRATIVE The proposed study will evaluate the impact of Family Connections, a family-based group intervention for adolescents and young adults (AYA) living with HIV and their family caregivers. The intervention seeks to increase social and family support and decrease self-stigma among AYA, so they may improve their medication adherence and achieve an undetectable viral load. Findings will fill a critical gap in available evidence-based intervention options for improving the HIV-related outcomes and wellbeing of HIV-positive AYA in sub-Saharan Africa.